Role of prelimbic cortical endocannabinoid signaling in enhanced cocaine-seeking behavior following combined repeated stress and cocaine use in rats

Project summary/Abstract
Addiction remains a vast problem in the United States and complicating the issue is the lack of FDA-approved
medications for the treatment of cocaine use disorder (CUD) making it a critical unmet need. A difficulty in
identifying treatment options is that CUD is multi-faceted involving interactions among several external factors,
including stress, which is unavoidable in daily life. Despite the prevalence of stress in human populations of
CUD, most pre-clinical addiction research does not incorporate stress as a factor during periods of drug use.
To examine the importance of stress-cocaine interactions on cocaine use and seeking behavior we use a
model where, in rats demonstrating otherwise stable cocaine self-administration (SA), a stressor delivered
daily at the time of cocaine SA, escalates cocaine intake and enhances cocaine-seeking behavior. This likely
involves neurobiological mediators that connect stress-responsive and reward systems in the brain, such as
endocannabinoid signaling (eCB). In support of this, systemic administration of a cannabinoid receptor 1
antagonist attenuates cocaine-induced reinstatement only in rats with a history of stress. Furthermore, we have
localized this effect to the prelimbic cortex (PrL), a key site for regulation of stress and drug-seeking behavior.
Importantly, eCB signaling, through attenuation of inhibitory neurotransmission, is well positioned to regulate
PrL pyramidal neuron activity and output which ultimately results in expression of enhanced cocaine-seeking
behavior. This proposal tests the novel hypothesis that repeated stress at the time of cocaine SA produces
long-lasting upregulation of eCB signaling in the PrL leading to increased pyramidal neuron activity and drug-
seeking behavior through dysregulated GABAergic signaling. To test this hypothesis, we will use behavioral,
molecular, and neurophysiological techniques to assess the involvement of PrL eCB signaling in the long-term
consequences of repeated stress-cocaine interactions. First, we will assess the role of PrL eCB signaling, via
pharmacological manipulation, in enhanced cocaine-induced reinstatement in stress-escalated rats. We will
then identify how combined repeated stress and cocaine SA regulates PrL eCB signaling by quantifying cell
type-specific changes in molecular components of the eCB system using fluorescent in situ hybridization, and
measure changes in PrL eCB content with mass spectrometry following cocaine-induced reinstatement. Lastly,
we will examine changes in eCB-mediated inhibitory synaptic plasticity that are associated with enhanced
cocaine-induced reinstatement, using whole-cell patch clamp recordings in the PrL. We will also use in vivo
fiber photometry measurement of Ca2+signaling to identify the contribution of eCB signaling to changes in PrL
pyramidal neuron activity associated with enhanced cocaine-induced reinstatement. These studies will provide
much needed information about how stress-drug interactions regulate prefrontal cortical circuits and has
treatment implications for those with CUD, especially for those for whom stress is a predominant contributing
factor by identifying unique neurobiological mechanisms that may provide therapeutic targets.

Public health relevance
Project Narrative Cocaine use disorder (CUD) remains a vast problem in the United States due, in part, to the high economic and health costs, and, unlike other drugs of abuse, there is no FDA-approved medication for treatment. Although there are many factors that influence CUD, there is a strong interaction between stress and drug use in human cocaine users which is problematic as stress is an unavoidable and powerful contributor to CUD. The proposed research is relevant to human health sciences as understanding the neurobiological mechanisms that are responsible for the long-term consequences of stress-drug interactions on susceptibility to drug-seeking behavior remains an important and necessary area of study with the ultimate goal of developing new and more effective therapeutic strategies for managing CUD.